Precision Medicine for All of Us Researchers Collective

The All of Us Research Program has created a national research dataset unprecedented in size and scope to advance precision medicine. However, data utilization is not yet commensurate with the power and potential reach. All of Us’ innovative cloud-based, centralized data governance requires broad professional development training for researchers, with a focus on informatics literacy and technical resources to support analysis within the All of Us Researcher Workbench (AoURW). The University of Arizona (UArizona)-Banner AoU team will address this challenge through five Aims derived from our extensive experience leading interdisciplinary scientific teams to utilize AoURW and creating programs to engage researchers in biomedical and health sciences research. Aim 1: Advance and manage our Biomedical Informatics Core (BIC) support team dedicated to assist All of Us researchers nationally and empower them to conduct research in the AoURW. Aim 2: Maintain and expand the All of Us Data Fellows program to train and mentor researchers in leveraging the AoURW and subsequently engage in outreach at their own institutions to promote All of Us-focused research projects and awareness. Aim 3: Maintain an Advisory Council (AC) to oversee all initiatives. Aim 4: Maintain our existing partnership with the Pharmacogenomics Global Research Network (PGRN) to engage researchers in precision medicine. Aim 5: Aid All of Us in improving the AoURW to ensure data and resource availability and usability. Aims 1-5 will cultivate an active and sustainable pool of All of Us-focused researchers empowered by our resources and AoURW’s directive to advance precision medicine. We will engage researchers to utilize the AoURW using active engagement strategies, while maintaining the flexibility to work with existing All of Us partners and extend All of Us resources. Our UArizona-Banner All of Us team will assess the impact of our activities, disseminate promising practices to the broader scientific community, evaluate our initiatives against All of Us programmatic objectives, and ensure that our researchers’ perspectives inform AoURW development—driving All of Us further toward scientific discovery.

Public health relevance
The All of Us Research Program has created a national research dataset that is unprecedented in size and scope to advance precision medicine. This project aims to enable researchers to effectively and rigorously utilize All of Us data for scientific discovery. The proposed research is relevant to public health because it has the potential to accelerate biomedical research, generate new knowledge, and reduce the public health burden of a wide variety of diseases. Thus, the proposed projects are relevant to the part of the NIH mission that pertains to a focus on improving population health and supporting rigorous, reproducible, and unbiased research.